PediAtric ReseArch of Drugs, Immunoparalysis and Genetics during MODS (PARADIGM)

Project Summary/Abstract
PediAtric ReseArch of Drugs, Immunoparalysis and Genetics during MODS (PARADIGM)
Failure of the immune system is common in the setting of pediatric multiple organ dysfunction syndrome
(MODS) and is associated with high risks for secondary infection, persistent organ failure, and death.
When severe, this is termed “immunoparalysis.” This form of immune system failure can be defined as
reduced ability of whole blood to produce the cytokine tumor necrosis factor (TNF)-α upon ex vivo stimulation
with lipopolysaccharide. We have developed a highly standardized, small-volume, easy-to-process
approach to this testing that is used in multi-center studies of immune function. Our group has studied
immunoparalysis for nearly two decades in children from varying diagnostic groups including sepsis, trauma,
cardiopulmonary bypass, and viral infections, but these studies have been limited by small sample sizes.
Although our testing approach has identified thresholds of innate immune function that strongly predict adverse
outcomes from pediatric critical illness, these thresholds may vary by diagnostic group and have not been
validated in a large independent cohort. It is well known that certain conditions and treatments overtly result in
impaired immune function (e.g. malignancy), but the implications of most acute and chronic diagnoses on
immune function remain unclear. In addition, many commonly used drugs in the pediatric intensive care unit
(PICU) (e.g. hydrocortisone, sedatives, analgesics) have unintended immune effects, though their magnitude is
unclear. Lastly, the influence of the host genome on immune function in this setting is unknown. Clinical trials
are ongoing in critically ill adults and children targeting the reversal of immunoparalysis, but there are currently
no studies targeting the prevention of immunoparalysis, largely due to a lack of understanding of risk factors.
The overall goal of our research program is to reduce the incidence of immunoparalysis and its associated
risks for infection, organ failure, and death. The PARADIGM study is a 1400-subject, multi-center, prospective,
observational study to test the central hypothesis that the risk for development of immunoparalysis in children
with MODS can be predicted from diagnosis-specific, treatment-specific, and host-specific factors. Goals to
be achieved for the first time as a result of the PARADIGM study include: confirmation, in a very large
cohort of children with MODS, of thresholds of TNFα production capacity that are associated with death,
prolonged organ dysfunction, and nosocomial infection; identification of diagnoses and ICU therapies that
predispose children to, or prolong, immunoparalysis; and identification of candidate host genomic factors that
may predispose children to, or prolong, immunoparalysis independent of diagnostic or treatment factors.
This work will advance the field through 1) improved design of targeted clinical trials of immune stimulation; 2)
avoidance of treatment regimens that predispose children with MODS to immunoparalysis; 3) development and
testing of precision-medicine approaches to immune care in the PICU; 4) collection of a critical mass of data on
the TNFα response sufficient to move the assay from the research environment to the clinical laboratory.

Public health relevance
Project Narrative Relevance Severe immune failure, termed immunoparalysis, is a common but poorly understood feature of multiple organ dysfunction syndrome (MODS) in children. Immunoparalysis has been associated with increased risks for prolonged organ dysfunction, nosocomial infection, and death in this population but key knowledge gaps remain. The overall objectives of this study are to identify thresholds of immune function that predict adverse outcomes in children with MODS, and to identify extrinsic (diagnosis- and treatment-specific) and intrinsic (genomic) factors that predict the risk of immunoparalysis. Understanding these factors will allow for the development and testing of preventative and empiric treatment strategies aimed at optimizing immune function in critically ill children. The PARADIGM study therefore has the potential to impact both the clinical management of children with MODS and the design of future clinical trials aimed at preventing or reversing immunoparalysis.